Admin

The PERLHS Administrative Core (PAC) provides the structures, norms and support for PERLHS to
encourage a shared mission among participants and partners, a facilitative environment, and access
to unique resources with the goal of providing a rich and supportive learning environment for our
scholars. The PAC provides the leadership, coordination and oversight of all PERLHS activities. PAC
will provide a stable infrastructure and capable leaders who will demonstrate effective coordination
skills and strong emotional intelligence. The coordination and oversight activities of the PAC will
include recruitment and selection of scholars, mentorship matching, connection of scholars to
resources, budget management, and other program administration activities. PAC will also be
responsible for facilitating collaboration among the cohort of scholars, the Cores, the funder, other
E-STAR grant recipients as appropriate, and with partnering entities and other stakeholders
including patients, caregivers, and patient and community organizations. To achieve this,
PAC will use frequent and effective communication to assure productive collaboration, in a setting
where all participants feel psychologically safe and respected, with recognition of their unique
backgrounds, talents and contributions. PAC is also responsible for evaluating the processes and
impact of PERLHS. With both formative and summative goals, PAC directors will measure, monitor,
report and interpret the impact of PERLHS. Namely, the PAC leadership will assess speciϐic training
program outcomes such as patient-centeredness of the research products (tools, policies,
publications), and effectiveness of the research dissemination. Additionally, PAC will conduct a
process evaluation to investigate the accomplishment of the speciϐic aims of each Core. Finally, PAC
will assess the reactions, knowledge, skills, attitudes, behaviors, goals accomplishment and
products of individual PERLHS scholars. The PERLHS mixed method evaluation will use
data sources that include survey data, program administrative documentation, and
interviews.